Investigating Vulnerable Cell Populations in Aging-Induced Circadian Clock Remodeling and Disruption

Project Summary
Disruption of circadian clocks—cell-intrinsic oscillators responsible for maintaining daily physiological and
behavioral rhythms—is an emerging hallmark of aging. While studies have shown that circadian clock outputs
remodel or diminish with age in various tissues, the specific cellular and molecular drivers of the bidirectional
relationship between aging and the circadian clock remain unknown. This project seeks to identify key cell
populations whose circadian rhythms are most impacted by aging and those that are most vulnerable
to loss of the circadian clock, aiming to understand how aging affects circadian rhythms across cell types
and how circadian disruption influences aging at cellular and molecular levels.
The main approach centers around high-throughput single-nucleus RNA sequencing of flash-frozen tissues. In
Specific Aim 1, I will profile sex-matched young and aged mice sampled every four hours over two days in
constant darkness, dissecting seven organs: brain, liver, heart, kidney, lung, colon, and skeletal muscle.
Clustering analyses will identify cell types, and circadian genes will be characterized using the JTK_Cycle
algorithm, comparing results across sex and age. I will map circadian cell-cell interactions through
ligand-receptor analysis to reveal age-related shifts in intercellular communication and perform transcription
factor enrichment analysis to uncover upstream regulators in cell types showing pronounced changes with
aging. In Specific Aim 2, I will perform single-nucleus sequencing on wild-type young and aged mice, Bmal1
knockout mice—a genetic model of circadian disruption—and aged mice exposed to chronic jet lag—an
environmental model of circadian disruption. This analysis will identify cell populations vulnerable to circadian
disruption and determine whether circadian disruption-induced "early aging" reflects natural aging or
represents a distinct pathology.
The outcomes of this study will enhance our understanding of the interplay between circadian rhythms and
aging, offering a roadmap for examining the circadian output of cell types involved in aging-associated
diseases such as Alzheimer's disease, Type II diabetes, major depressive disorder, and cardiovascular
disease. By uncovering the circadian rhythms of disease-associated genes and receptors, the findings could
inform therapeutic timing and improve chronotherapy by aligning drug delivery with the biological rhythms of
specific cell types. With the mentorship of my sponsor, co-sponsor, thesis committee, and the support of this
fellowship, I am confident I will be well-prepared to pursue this project and achieve my goal of becoming a
physician-scientist and an independent investigator in the field of aging biology.

Public health relevance
Project Narrative Disruption of circadian clocks—a condition where the body's internal rhythms are altered—is linked to a range of age-associated diseases like Alzheimer's and cardiovascular disease, which exhibit time-of-day-specific symptoms and are exacerbated by circadian-disruptive lifestyles such as night shift work. This project aims to identify the specific cell types in the brain and body that are most susceptible to aging-induced circadian clock remodeling by analyzing their transcriptional circadian rhythms at the single-cell level, as well as cell populations that are most vulnerable to circadian clock disruption. Identifying these circadian dynamics can inform the timing of therapies for aging-related disease cell types, potentially improving treatment outcomes in these diseases through optimized chronotherapy.